ZDV, DDI PLUS DOUBLE BLINDED NEVIRAPINE VS COMBINATION, ZDV PLUS DDI

A comparative study of a combination of zidovudine, didanosine, and double blinded nevirapine versus a combination of zidovudine and didanosine.